U-RISE at Rutgers University - Camden

Rutgers University-Camden (RUC) seeks U-RISE grant support to enhance its success in promoting research and
academic achievement for diverse STEM students. The U-RISE program aims to recruit and train talented students from
underrepresented groups for competitive Ph.D. programs, leveraging RUC's diverse student population, exceptional
mentors, strong institutional commitment, and strategic location.
The proposed training plan comprises three tiers: Pre-URISE, U-RISE, and Certificate of Life Science Research program
(CLSR), designed to accommodate students with varying eligibility and interest in biomedical research careers. The
program's core values include diversity, academic excellence, research, community, leadership development, professional
development, resilience, and mentorship. Pre-URISE initiatives, such as the Summer Bridge Program, Exploring Careers
in Biology course, and research shadowing opportunities, aim to increase career awareness, retention in STEM majors,
and identify potential U-RISE scholars.
A range of research opportunities and training programs foster scientific research, development, and collaboration among
undergraduate students. These include the Exploring Research in Biology program, Summer CURE program, Curricular
Research Courses, and Biology Day. The U-RISE program provides comprehensive research training, including curricular
research courses, responsible conduct of research and lab safety training, a U-RISE handbook, fostering a sense of
belonging and community, promoting personal and academic growth, and offering mentoring and advising.
The program's primary objective is to select and support underrepresented students in STEM fields, focusing on pursuing
a Ph.D. or M.D./Ph.D. degree and research career. It will accept six students per cohort, retaining scholars by addressing
financial, academic, and personal barriers through continuous advising, individualized academic support, tailored
workshops, and mentoring. Community-building initiatives help foster a sense of belonging and mutual support. The U-
RISE program builds on the success of the previous MARC program to further support underrepresented students in their
academic and professional trajectories, developing essential skills, exposing them to the biomedical research field, and
creating personalized goals for each student. Key activities in the training plan emphasize skill development and
successful transition into and completion of biomedical, research-focused higher degree programs, leading to intended
trainee outcomes of increased representation and success in biomedical research careers.

Public health relevance
The mission for the U-RISE at Rutgers University - Camden program is to increase the number of well-prepared students from underrepresented groups for highly selective Ph.D. or combined M.D.-Ph.D.-level training in the biomedical sciences. The U-RISE at Rutgers University - Camden program will achieve this mission by expanding and supporting the established curricular research training curriculum.